CANCER CENTER

The Armand Hammer Center for Cancer Biology at The Salk Institute seeks to understand fundamental aspects of biology related to cancer, with the ultimate goal of reducing cancer incidence, morbidity and mortality. The Center operates as a single coordinated program, with research in the areas of genes and growth control, gene organization and expression, and differentiation and development. This Cancer Center Support Grant (CCSG) renewal application requests support for professional personnel, planning and evaluation, development and shared resources, including secretarial services, glassware, media and cell culture, shared equipment, flow cytometry and animal facilities, to support the competitively funded, peer-reviewed research projects in the Center.